In vivo cell kinetics and imaging of chronic graft-versus-host-disease

We first characterized immune subsets in lymphoid and target organs within the cGVHD pre-clinical model. We then completed in vivo cell kinetics experiments in the said model, and identified differential patterns for cGVHD versus control cohorts. We, then, developed a non-radioactive imaging modality for cGVHD. So far, we have been able to image cGVHD-affected organs in the pre-clinical setting, while our future efforts will be directed towards developing a clinical imaging modality for cGVHD-affected patients.